Improved 3D EPI for Pre-Surgical Mapping of Epilepsy

Project Summary
In pediatric epilepsy patients with drug-resistant seizures, surgical resection is the most effective treatment
option. The goal of resective surgery is to maximize removal of epileptic foci to attain seizure-freedom while
minimizing damage to surrounding brain regions to avoid permanent post-surgical functional loss. Functional
MRI enables rapid and non-invasive pre-surgical mapping of language, motor skills and other critical functional
brain regions with high spatial resolution. However, excessive head motion presents a major limitation for
acquiring high-quality fMRI in pediatric patients with focal brain lesions, who usually have difficulty remaining
still for long fMRI scan durations. Unfortunately, current retrospective and prospective approaches cannot
adequately compensate for the complex effects of motion in fMRI. As echo planar imaging (EPI) is highly
susceptible to local magnetic field variations, motion-induced geometric distortions and blood oxygenation
level-dependent (BOLD) contrast changes can lead to potentially significant mislocalization of activation
regions, even with accurate head motion tracking. The overarching goal of the research proposed under this
application to the NIH is to dramatically improve the quality of fMRI for pre-surgical mapping in pediatric
epilepsy patients. We are proposing a solution based on 3D EPI, which is more robust to spin history artifacts
and has higher signal-to-noise ratio (SNR) compared to conventional 2D EPI, combined with real-time motion
and field compensation. In particular, we will use ultra-fast free induction decay (FID) navigators, which can be
embedded in each shot of the 3D EPI acquisition without affecting BOLD contrast or reducing acquisition
efficiency. These navigator measurements will be used to produce accurate motion and field estimates that
can be used to update the imaging volume and magnetic field in real time. We hypothesize that this improved
functional MRI acquisition strategy will produce technically useful activation maps in pediatric epilepsy patients
evaluated for a resection surgery at a higher rate than previously thought possible. To achieve these ambitious
goals, we will undertake the following specific aims: 1) develop and evaluate a novel technology using FID
navigators to measure head motion and magnetic field fluctuations in multi-shot 3D EPI; 2) develop and
evaluate prospective motion correction and dynamic shimming utilizing real-time motion and field
measurements; 3) apply and evaluate motion and distortion compensation in fMRI of pediatric epilepsy surgery
candidates. If successful, our project will facilitate widespread clinical adaptation of fMRI for pre-surgical
mapping in epilepsy, and enable high resolution fMRI for research studies in incompliant patient populations.

Public health relevance
Project Narrative Epilepsy surgery can result in seizure freedom or a marked reduction in seizures in approximately two-thirds of children with intractable seizures who have been carefully selected, with minimal adverse functional loss. Functional magnetic resonance imaging (fMRI) is an important non-invasive tool that allows the neurosurgeon to precisely map regions of the brain supporting critical functions that should be preserved; however, excessive head motion can lead to mis-identification of these regions, with direct implications for treatment. The proposed project, “Improved 3D EPI for pre-surgical mapping of epilepsy” promises to deliver a highly innovative imaging method capable of producing high-quality functional maps in the presence of uncontrolled head motion by tracking the position of the head and updating the acquisition in real-time.